Genetic Risk for Aggressive Thyroid Cancer in an Understudied Male Predominant Veteran Population

Thyroid cancer incidence is rising with over 44,000 new cases in 2021 in the United States alone, making it the
most common endocrine malignancy. There is a critical gap in knowledge around environmental and genetic risk
modifiers for aggressive high-risk thyroid cancer that is a barrier to accurate risk estimation, personalized
diagnosis, prognosis, and clinical care. In the Veteran and military populations, there are increased diagnoses
of thyroid cancer and an association with Agent Orange exposure. Interestingly, in general, males have a two to
three-fold increased mortality associated with thyroid cancer compared to females, despite thyroid cancer being
almost three times more common in females. In fact, male sex is associated with a worse overall and recurrence-
free survival. In addition, there is a strong hereditary component to this complex disease. Cancer registries
estimate genetic effects with highest relative risk of thyroid cancer seen in male relatives of male probands and
lower relative risk in female relatives of female probands. Taken together, all of these data suggest there is a
sex dimorphism in thyroid cancer with males having more aggressive disease; however, the underlying
mechanisms are unknown. We propose to use the Million Veteran Program (MVP) cohort of over 950,000
enrolled Veteran volunteers to investigate the genetic etiology of aggressive thyroid cancer. Because the MVP
is male predominant and males have more aggressive thyroid cancer, we propose to perform sex-stratified
genome-wide association studies (GWAS) to identify genetic variants for high-risk of recurrence or metastatic
thyroid cancer. We also propose to develop a sex-specific polygenic risk score (PRS) to identify patients pre-
operatively who are at the highest risk to improve morbidity and mortality. In Aim 1, we will determine the
inherited genetic etiology for high-risk differentiated thyroid cancer in the male predominant Veteran
population. We will perform a series of sex-stratified GWAS using the MVP clinical and genomic data to identify
variants associated with developing high-risk thyroid cancer (and not benign thyroid nodules) seen more often
in males. In Aim 2, we will determine the utility of a sex-specific PRS for predicting high-risk differentiated
thyroid cancer. We hypothesize that sex-specific PRS will identify patients at the time of presurgical diagnosis
who are likely to have high-risk disease and will benefit from more aggressive surgical and adjuvant therapy to
reduce morbidity and mortality. The impact of the results of the proposed studies will be transformative to the
clinical care for Veterans, and others, with thyroid cancer, especially those with the more aggressive form
predominantly seen in males. The results may also provide insight into other endocrine neoplasms and cancers
with sex dimorphisms.

Public health relevance
Thyroid cancer is the most common endocrine malignancy. Although females are almost three times more likely to develop thyroid cancer, males are almost three times more likely to die from the disease. This sex dimorphism suggests that there are sex-specific genetic risk modifiers for aggressive thyroid cancer. The Million Veteran Program (MVP) has enrolled over 950,000 Veteran volunteers in a genotyped and phenotyped biobank. Given the male predominance in the Veteran population and the more aggressive thyroid cancer found in males, there is an unmet need to understand the genetic etiology that contributes to the sex dimorphism seen with aggressive thyroid cancer. Therefore, we propose to perform a series of sex-stratified GWAS analyses to identify the genetic variants for high-risk thyroid cancer and develop a polygenic risk score to identify patients pre-operatively who are at the highest risk, in order to guide surgical care and adjuvant therapy as well as ongoing surveillance.